Stimulation of Cervical Excitatory Interneurons to Restore Breathing After Chronic Cervical Spinal Cord Injury

Dysfunctional breathing is a significant cause of morbidity and mortality after cervical SCI (cSCI). The ability to
restore breathing in the chronic phase after cervical SCI (cSCI) is an overwhelming yet important goal. The
diaphragm, the major inspiratory muscle, is innervated by phrenic motoneurons (PMNs) located in the cervical
spinal cord (C3-C5). Cervical interneurons synapse onto PMNs and discharge in synchrony with phrenic inspir-
atory output and modulate breathing. Premotor neurons within the rostral ventral respiratory group of neurons
(rVRG) in the brainstem provide the main inspiratory drive to the spinal respiratory circuitry. Cervical spinal cord
injury (SCI) disrupts the communication between rVRG and the spinal respiratory circuitry resulting in significant
respiratory compromise. We recently demonstrated that pharmacogenetic stimulation of cervical excitatory in-
terneurons (eINs) immediately after cSCI rescues breathing in mice; however, it is not known if this strategy will
be effective in improving breathing in the chronic phase of cSCI. At the chronic stage, the respiratory network is
known to undergo significant modifications. Moreover, our previous work in non-traumatic compressive injury to
the cervical spinal cord demonstrated that cervical eINs play an integral role in promoting plasticity and main-
taining ventilation despite a significant loss of PMNs. Given that cervical eINs integrate into the respiratory net-
work, and they are necessary for the spontaneous respiratory recovery, they emerge as critical therapeutic tar-
gets for respiratory recovery in the chronic phase after traumatic cSCI. We hypothesize that providing selec-
tive excitatory input to surviving PMNs at the late stage of cSCI will enhance PMNs output and respiratory
recovery. The first objective of this proposal aims to gain more significant insights into the status of the respira-
tory neural network after chronic cSCI. The second objective of this proposal will examine a novel treatment
strategy involving selective stimulation of cervical eINs to promote respiratory recovery in the chronic phase after
cSCI.
In aim 1, we will assess the survival of PMNs following C2 hemisection injury (C2Hx) using the monosynaptic
retrograde tracer Cholera Toxin Subunit B to specifically track the PMNs. In the second part of Aim 1, we will
simultaneously map the input-output connectivity of the cervical respiratory elements, the PMNs and the
prephrenic cervical eINs, in the naïve-uninjured state and after cSCI. In Aim 2, we will selectively stimulate the
cervical eINs in the region of the phrenic nuclei after chronic cSCI using the DREADD technology. This technique
has innovative applications due to its ability to activate or silence neuronal populations non-invasively. The effect
of stimulating cervical eINs on promoting respiratory recovery after chronic cSCI will be assessed using electro-
myography and whole-body plethysmography. The expected outcomes of the proposed experiments are inno-
vative as it will increase our knowledge of the spinal respiratory network after chronic cSCI and facilitate the
development of a novel strategy to restore breathing in the chronic phase of cSCI. These results will have a
meaningful positive impact on the health and survival of veterans with SCI, and the strategy examined here has
the potential to be implemented for weaning patients off mechanical ventilation in the chronic phase after cSCI
when promoting recovery has remained a daunting task. Additionally, SCI represents a significant focus area of
the veterans, about 7% of those living with SCI in the United States have sustained their SCI while actively
serving. Injuries are often due to penetrating injuries such as from gunshots or high-powered explosive devices.
As such, military personnel with SCI face even more long-term disabilities than those endured by civilians with
SCI, and the issues more pronounced in veterans with cSCI and respiratory dysfunctions.

Public health relevance
Dysfunctional breathing is the major cause of morbidity and mortality after traumatic cervical spinal cord injury (cSCI). It often necessitates assisted ventilation, thus stressing the need to develop strategies to restore breathing. Individuals with cSCI continue to suffer from respiratory complications throughout life. As the incidence of spine trauma has been increasing in modern warfare and the incidence of progressive cervical spinal cord injury increases due to an aging veteran population, SCI will continue to provide a significant challenge to the Veterans affairs. This proposal examines a novel and clinically impactful treatment option with a particular focus on promoting respiratory plasticity of the spared respiratory neural network at a late stage after cSCI. Promoting recovery in the chronic phase is an extremely challenging task. By improving the respiratory function of military veterans who have sustained a cervical SCI, a significant number of health complications and mortality will be prevented.